Two photon microscopy and optical clearing for volumetric imaging of melanoma surgical margins

Complete resection of melanoma is essential to patient survival, but tools for assessing the irregular borders of
melanoma during surgery are rudimentary. Current surgical management emphasizes either multiple days of
surgery with paraffin processing to evaluate margins or wide local excision that removes large margins of healthy
tissue to minimize untreated residual disease. In either case, the need for large and disfiguring margins around
melanoma stems from the diffuse and three-dimensional pattern of spread which is difficult to assess from two-
dimensional histology. The goal of this R21 application is to develop a new approach to melanoma surgery
based on comprehensive volumetric imaging of the tissue margin to determine the true extent of
melanoma involvement. Using rapid molecular labeling, and two photon fluorescence microscopy
combined with optical clearing (cTPFM), whole margins can be rendered clear and then imaged from the
surface down to the level of tumor involvement, enabling complete assessment of tumor boundaries more rapidly
and more accurately than current techniques such as rush paraffin sections. Following imaging, therapy can be
directed to insufficient margins, potentially improving both tissue conservation and patient outcomes. This
entirely new approach to melanoma therapy leverages previous experience in fluorescent labeling and
proposes advances in rapid tissue clearing and new technology for high throughput imaging to clear and image
specimens significantly faster than the current standard. The aims for this proposal are as follows: Aim 1, Task
1 will develop automated tissue clearing equipment that can reproducibly apply reagents in sequence to large
numbers of specimens and conduct studies to establish non-interreference with histology. Task 2 will develop
improved imaging equipment specifically for dermatologic surgery and clearing. Task 3 will develop and integrate
fundamental advances in two photon fluorescence detection technology, enabling a 100-fold increase in imaging
speed by scanning multiple depths in parallel. Aim 2, Task 1 will establish the sensitivity and specificity of TPFM
by clearing and imaging historical melanoma specimens and then comparing histological evaluation of TPFM
images to paraffin sections. The difference between conventional 2D and comprehensive 3D imaging will be
evaluated in a blinded study. Task 2 will conduct exploratory intrasurgical imaging by recruiting patients
being treated for melanoma and then clearing and imaging entire margins prior to histological processing,
demonstrating that intrasurgical mapping of entire melanoma margins is feasible. Successful completion of this
project would demonstrate a new approach to melanoma treatment that emphasizes tissue conservation,
improves patient outcomes by detecting insufficient margins and reduces the need for complex surgical
reconstruction.

Public health relevance
Project Narrative This project proposes a new approach to margin evaluation during surgery for melanoma based on fast optical clearing to render the entire excision transparent, and then volumetric imaging of the excised tissue using two photon microscopy. By imaging the entire extent of the tumor during surgery, it should be possible to guide to surgeons to areas of residual cancer while protecting healthy tissue. Studies will be conducted to develop this technique and then test it in historical specimens and then patients at the University of Rochester Medical Center.